Posttranscriptional modification in lung development and regeneration

SUMMARY
Lung regeneration involves the reuse of signaling pathways that are important for organ development. Previous
studies have shown that these pathways converge to regulate the transcription of downstream targets. In
contrast, little is known about the modifications of the resulting transcripts. In this proposal we will fill the
knowledge gap and provide initial insights into the mechanism by which posttranscriptional regulation controls
lung development and regeneration. We will study how Mettl3/14 complex-mediated RNA modifications are
involved in lung epithelial differentiation. Our central hypothesis is that Mettl3/14-mediated m6A deposition
on transcripts including Sox9 is critical for lung development and regeneration. We will test the hypothesis
with three specific aims. Aim 1 will address the mechanism by which Mettl3/14-mediated RNA modification
regulates lung development. We will use a combination of mouse genetics, Nanopore, m6a-SAC-sequencing
and proteomics to identify and functionally test mRNA substrates that are modified by the Mettl3/14 complex.
We will also study whether Sox9 transcripts are modified by the methylation complex. Aim 2 will focus on the
Mettl3/14 complex-mediated RNA modification in alveolar regeneration. We will also investigate the role of Sox9
in alveolar regeneration through Sox9 loss- and gain-of-function studies. Aim 3 will examine whether the function
of posttranscriptional regulation is conserved during the differentiation of human pluripotent stem cells-derived
lung progenitor cells. Combined with the findings obtained from Aim 1, Aim 3 is expected to offer candidate
transcripts that are regulated by the Mettl3/14 complex across species. Together these studies will help us gain
a better understanding of the normal mechanism regulating lung development, meanwhile enabling insights into
alveolar regeneration following injury.

Public health relevance
Narrative Although significant knowledge has been gained regarding the role of transcriptional regulation in lung development and regeneration, it remains largely unknown how posttranscriptional regulation is involved in these processes. Our proposed study will determine the mechanism by which the Mettl3/14 complex-mediated RNA modifications controls lung development and regeneration. The knowledge gained will provide a framework for promoting recovery following injury, meanwhile identifying new players critical for lung development.